The Mississippi ESTEEMED Scholars Program

Project Summary
The Mississippi ESTEEMED Scholars Program is designed to promote equitable outcomes for undergraduates
in bioengineering/STEM fields who come from underrepresented backgrounds. Mississippi has the highest
poverty rate in the nation and grapples with educational challenges, including having most of the state designated
as a critical needs area for mathematics and science education. Thus, the pathway to a biomedical engineering
career is challenging. To help address these issues, we propose the ESTEEMED program to facilitate the
success of incoming freshmen students pursuing biomedical engineering (BME). The program focuses on
supporting BME curriculum preparation and building scientific identity, ensuring that students, particularly those
from underrepresented backgrounds, are well-equipped to navigate the demanding curriculum and persist
through to graduate STEM careers The long-term goal is to train the next generation of scientists that will
transform understanding of disease prevention, detection, diagnosis, and treatment through engineering and
diversify the biomedical workforce. Transitional programming designed to increase recruitment, retention, and
research success of young scholars affiliated with the University of Mississippi will increase the preparedness of
future doctoral degree applicants in fields like bioengineering and bioimaging. The program includes a summer
bridge that transitions students from high school into the University of Mississippi. They will get a head start on
coursework, be trained in responsible conduct of research and laboratory safety, be introduced to foundations of
electronics, conduct 3D printing, and be exposed to scientific equipment across numerous facilities. During the
academic year, mentorship meetings with program leaders will occur, and individual development plans will be
utilized to plot a course towards a career trajectory in STEM for the students. Supplemental self-paced computer
programming training will be provided to enhance the preparedness for future coursework, projects, and careers.
In addition, students will choose from numerous local research mentors who run independent laboratories that
span fields in biomedical engineering, bioimaging, biology, chemistry, physics, and pharmacology. In their second
summer, students will receive support to apply to work in external laboratories with highly specialized skills. In
addition, during the academic year, students will have the opportunity to interact directly with successful scientists
and engineers in multiple engaging formats. Training will be provided to support student presentations of their
own laboratory projects to visiting scholars and at local symposia/regional conferences. Finally, this program will
support students to transition into an honors program on campus for their junior/senior years to continue their
trajectory toward graduate school in STEM fields.

Public health relevance
Project Narrative The Mississippi ESTEEMED Scholars Program is designed to train students from underrepresented backgrounds into STEM fields related to biomedical engineering and bioimaging. This program will match talented high school students from the region with educational and training opportunities that position them to have an impactful career in a STEM field. By strategically addressing education equity issues, fostering inclusion, and bolstering scientific identity confidence, the program not only promotes diversity in STEM but also contributes to the development of a skilled workforce capable of advancing healthcare and technological innovation, ultimately enhancing public health outcomes in underserved communities.